Probing the role of heterogeneity in streptococcal interactions

PROJECT SUMMARY/ABSTRACT
Streptococci are the most abundant microbes in the human oral cavity, with most people harboring multiple
species, and often even multiple strains of the same species (1-6). Further, while most species of oral
streptococci are not pathogenic, studies with selected strains have shown that streptococci can influence the
physical location and the virulence factor expression of oral pathogens such as Porphyromonas gingivalis (Pg),
Aggregatibacter actinomycetemcomitans (Aa), and Fusobacterium nucleatum (2, 3, 7-11). These interactions
influence the progression and severity of disease, as well as its resistance to treatment (7, 12-16). However,
these interactions also are governed by the traits that are known to vary across the genus, such as cell surface
structures and secreted organic acids (17, 18). Further, transcriptional heterogeneity, which results in
subpopulations, can further alter the behavior of microbes (19-23). Thus, while the abundant streptococcal genus
is thought of as an important mediator of pathogen behavior, it is not well understood how streptococcal-
pathogen interactions are impacted by genomic and transcriptomic diversity. In this study, the overarching
hypothesis is that genomic, phenotypic, and transcriptional heterogeneity impacts the interactions between
commensal streptococci and oral pathogens, and impacts infection. This grant aims to expand our understanding
of streptococcal-pathogen interactions by investigating diversity at two levels: genomic and transcriptional. First,
it will systematically characterize the interactions formed by taxonomically diverse streptococci with the
pathogens Pg and Aa in a phylogenomic framework (Aim 1). This work will identify the scale at which interactions
vary across the streptococcal genus and potentially identify new functions that mediate interactions with these
pathogens. Second, this grant will characterize the transcriptional heterogeneity in commensal streptococci that
result in subpopulations and ask how streptococcal-pathogen interactions influence, and are influenced by,
subpopulations (Aim 2). This Aim will significantly advance our understanding of the role of transcriptional
heterogeneity in oral commensal streptococci, how it varies taxonomically, and how it is altered by environmental
changes. Further, both Aims will consider the interplay of streptococcal diversity and interactions on spatial
patterning at the micron-level. Overall, this research will broaden our understanding of the role of streptococci
during oral disease.

Public health relevance
PROJECT NARRATIVE The widespread oral diseases, cavities and periodontitis, are caused through complex interactions between oral pathogens, commensal bacteria, and the host. This proposal investigates how the genotypic, phenotypic, and transcriptomic diversity impacts the interactions between streptococci and oral pathogens. These studies will broaden our understanding of the role of commensal streptococci in promoting health and disease in the oral cavity, potentially revealing new approaches to improve disease outcomes.